ISMRM workshop on MRI of Neuromodulation

Project Summary/Abstract:
During recent years, neuromodulation techniques such as transcranial direct current stimulation (tDCS),
transcranial magnetic stimulation (TMS) and deep brain stimulation (DBS), as well as alternative methods using
optical and ultrasonic modulations, have become an important means to study how complex neural circuits
interact in the brain, to manipulate human cognition and to treat brain disorders. Magnetic resonance imaging
(MRI) can now be performed either concurrently with or pre and post these neuromodulation techniques to
visualize their effects on the human brain, to understand the neurophysiological mechanism and to improve their
efficacy. This topic is highly relevant to the theme and growing interests of ISMRM for MRI guided therapy and
MRI with implants. It also aligns with the goals of the NIH BRAIN Initiative and public interest in brain-computer
interfaces such as Elon Musk’s Neuralink. The proposed ISMRM workshop on “MRI in Neuromodulation:
Target Engagement, Neural Mechanism, and Biomarker Development” will bring together a diverse group
of scientists and clinicians as well as industry partners who are interested in developing and applying advanced
MRI techniques to visualize, understand and quantify neuromodulation effects on the human brain. This
workshop will be the first of its kind on the topic of MRI in neuromodulation in ISMRM history. The proposed 2.5
days workshop will take place Oct 17-19, 2022 on the NIH campus in Bethesda MD. The program will be
designed for both senior investigators and junior scientists. The organizing committee will also emphasize
attendance by trainee members of ISMRM, underrepresented groups and engage the international research
community, and will work with industry partners to secure funding to provide travel support for trainees. The
meeting will include invited and proffered oral presentations as well as short power-pitch poster sessions. The
workshop’s schedule will integrate presentations with ample discussion periods covering advances in various
MRI techniques for neuromodulation (electromagnetic field mapping, functional connectivity, arterial spin labeled
perfusion and permeability, temperature and acoustic radiation force imaging etc), pre-clinical animal models
and cellular-level mechanisms of neuromodulation, and safety issues related to MRI with neuromodulation
devices. Existing and emerging clinical applications for MRI in neuromodulation and biomarker development will
be discussed between academic and industry partners.

Public health relevance
Project Narrative: The proposed ISMRM workshop on “MRI in Neuromodulation: Target Engagement, Neural Mechanism, and Biomarker Development” will bring together a diverse group of scientists and clinicians as well as industry partners who are interested in developing and applying advanced MRI techniques to visualize, understand and quantify neuromodulation effects on the human brain. This topic aligns with the goals of the NIH BRAIN Initiative and public interest in brain-computer interfaces, and may improve the treatment of a range of neurologic and psychiatric disorders.